Johns Hopkins Autoimmunity Center of Excellence

PROJECT SUMMARY
The overarching theme of the Johns Hopkins Autoimmunity Center of Excellence (ACE) is that distinct immune
cell subsets are the major drivers of immunopathogenesis in different autoimmune diseases, and that targeted
therapies at a critical juncture of disease trajectory will modify or halt the propagation of disease. The primary
clinical project led by Pavan Bhargava, MBBS, MD, proposes to selectively target effector-memory T cells, class-
switched memory B cells, and inflammatory microglia in secondary progressive multiple sclerosis (SPMS) by
blocking the potassium channel Kv1.3 using dalazatide. Utilizing, cutting-edge immunological, imaging and
biomarker assessments, this trial seeks to identify pathogenic immune cells driving disease in SPMS while
testing a novel treatment strategy that could be applied to a range of other autoimmune disorders. The alternate
clinical project led by Julie Paik, MD, MHS, proposes to target B-cells using a novel, third generation anti-CD 20
agent, ublituximab, early in the course of active, autoantibody positive myositis (excluding inclusion body
myositis). The current challenge in the therapeutic landscape of myositis is that B-cell depleting agents are
considered third line despite the wealth of literature supporting their efficacy. Therefore, this proposed Phase 2
randomized, double-blind trial of ublituximab in myositis can potentially lead to a paradigm shift in the utilization
of B-cell depleting agents as first-add on therapy to background immunosuppression. And lastly, the collaborative
project led by Elias Sotrichos, MD, seeks to perform deep phenotyping of single immune cells in the peripheral
blood and cerebrospinal fluid in neuromyelitis optica spectrum disorder (NMOSD) and myelin oligodendrocyte
glycoprotein antibody disease (MOGAD) to identify subsets that are involved in disease pathogenesis. All three
projects highlight the extraordinary cross-discipline synergy that exists at Johns Hopkins through the
collaborative resources of the Johns Hopkins Institutional Precision Medicine initiative. The establishment of the
Johns Hopkins ACE will further leverage the Multiple Sclerosis and Myositis Precision Medicine Centers of
Excellence to achieve the following aims: 1) Enable the implementation and execution of innovative, investigator
initiated therapeutic trials, (2) Discover key cellular drivers of autoimmunity through modification of immune
function with investigational therapeutic agents, and (3) Increase interdisciplinary collaborations within Johns
Hopkins and the broader ACE network to advance the understanding and treatment of autoimmune diseases.
These aims will be achieved through the resources of the Administrative coordination group which will be a
conduit to integrate all scientific and administrative oversight of the Hopkins ACE. Additionally, the funds
management core will provide support to studies throughout the ACE network, while the Biobanking core can
handle a variety of samples and will be an indispensable resource to support the clinical research projects that
are ongoing in the ACE network.

Public health relevance
PROJECT NARRATIVE Autoimmune disorders affect millions of people worldwide and impose a significant burden on society, given the age groups they affect and their chronic nature. Current treatments either do not impact certain autoimmune diseases or are associated with significant adverse effects due to eliminating both pathogenic and protective immune cells. The Johns Hopkins Autoimmunity Center of Excellence will perform clinical trials in patients with multiple sclerosis and myositis, in addition to a collaborative project in participants with neuromyelitis optica (NMO) and myelin oligodendrocyte glycoprotein antibody disease (MOGAD) with the goal of improving our understanding of the specific immune cell subsets driving these disease processes and ultimately identifying novel targeted treatment approaches for autoimmunity.